NARCH 12

Project Summary
Major health inequities continue to impact tribal nations, yet a serious shortage of scientists who conduct tribally
engaged research aimed at alleviating health disparities affecting American Indian (AI) people persists. For
several years, Cherokee Nation, the University of Oklahoma (OU) system and the Oklahoma Medical Research
Foundation (OMRF) have partnered to address this issue by building tribal research capacity through the Native
American Research Centers for Health (NARCH) mechanism. In this cycle of NARCH funding, the partnership
among Cherokee Nation, OU and OMRF continues and, importantly for student career enhancement, expands
to include the Oklahoma State University (OSU) system as a key partner for student career enhancement
activities. The overall mission of Cherokee Nation NARCH is to develop durable research capacity within the
context of a Native American tribal nation to address health inequities affecting the AI population of northeastern
Oklahoma. To achieve this goal, the five Specific Aims of Cherokee Nation NARCH are:
1. to strengthen administrative infrastructure, including a Leadership Team (LT) and a Tribal-Campus
Advisory Committee (TCAC), that ensures integration of career enhancement, capacity building and research
activities;
2. to educate the next generation of researchers to engage meaningfully with Cherokee Nation in the context
of tribal research, focusing on undergraduate, graduate and health professions students;
3. to build tribal capacity by developing a set of research codes to govern the conduct of genomic and other
biomedical research predicated on the concept of tribal data sovereignty;
4. to conduct innovative research capable of seeding future research projects performed by researchers
seeking to work within the Cherokee Nation setting; and
5. to evaluate activities of the partnership, including monitoring progress of student career enhancement,
capacity building, and research projects, and evaluation of the overall Cherokee Nation NARCH program.
Cherokee Nation NARCH provides a crucial opportunity to solidify the foundation for tribal capacity in health
disparities research. The addition of OSU strengthens this project, as OSU has demonstrated remarkable
success in the education of AI students in scientific and health professions fields, including the advent of the first
tribally affiliated medical school in the US. Cherokee Nation NARCH therefore provides an unprecedented
environment in which a Tribe, two research-intensive universities with large NA student populations (OU and
OSU), and a biomedical research foundation (OMRF) will work synergistically to reduce the unacceptable
disparities in health that continue to affect AI people.

Public health relevance
Project Narrative Natives suffer from a range of health inequities. CN NARCH will expand tribal capacity to address these disparities through a coordinated research involving career enhancement, capacity building, and research activities.